Engineered tolerogenic exosomes for treating type 1 diabetes autoimmunity

Project Summary / Abstract
The objective of this project is to engineer an exosome-based therapeutic platform to counteract pancreatic
beta-cell autoimmunity as a strategy to treat or prevent type 1 diabetes (T1D). We hypothesize that exosomes
can provide a virtually unlimited source of nanoparticulate, cell-free MHC-complexed antigen that, alongside
appropriate negative regulators of immunity, can induce antigen-specific tolerance to beta cell autoreactive T
cells without compromising system-wide immunity.
Exosomes are small (30-150nm) biologically active membrane vesicles secreted by most cell types.
Exosomal membranes are composed of a lipid bilayer with many lipid rafts that are enriched in cholesterol,
sphingomyelin, and ceramide, giving them a long circulatory half-life in vivo and an extended shelf life. Exosomes
can display immunostimulatory or immunoregulatory functions. Antigen presenting cells secrete large numbers
of exosomes enriched in MHC peptide complexes and the adhesion molecule ICAM-1, enabling them to interface
directly with T cells to control immune outcomes. In general, particulate antigen, such as that associated with
exosomes, is far more immunologically potent than soluble, monomeric antigen.
Our hypothesis and objective will be tested through performance of the following aims:
• Aim 1 will establish that exosomes can be engineered to overexpress the immunoregulatory molecule
programmed death-ligand 1 (PD-L1) and can act through this molecule and native MHC loaded with
peptide antigen to suppress activated T cells in an antigen specific manner in vitro.
• Aim 2 will evaluate the in vivo performance and mechanisms of tolerogenic exosomes in a mouse model
of autoimmune diabetes.
The prevalence of T1D in the U.S. continues to increase, despite growing knowledge of the pathogenesis
and natural history of the disease, as well as better treatment options. Therefore, there is a significant need for
a curative therapy that addresses the underlying autoimmune aspects of the disease by interfacing with
autoreactive T cells. The key element of this proposal is directing multimeric, exosome-bound PD-L1 in an
antigen specific manner to suppress diabetogenic T cells, thus addressing autoreactivity without compromising
systemic immunity.
The training environment shared between the UF Biomedical Engineering department and the UF Diabetes
Institute allows for unique opportunities to collaborate and receive expert advice from leaders in both biomaterials
and T1D autoimmunity. Training goals will be met by attending weekly seminars with leading researchers in
biomaterials and T1D from around the country, professional development seminars offered through the College
of Medicine, College of Medicine Endocrinology Grand Rounds, and weekly journal clubs.

Public health relevance
Project Narrative Diabetes affects over 30 million Americans resulting in health care costs that approach $250 billion annually, with approximately 1.5 million adults and children having type 1 diabetes. Here, we are proposing an antigen- specific, cell-free therapy for inducing immune tolerance in type 1 diabetes while maintaining healthy systemic immunity, based on exosomes as carriers of immunological information. This research will lay the foundation for patient-personalized tolerance treatments in autoimmunity that can impart much of the functionality of adoptive immune cell therapies while providing an enhanced safety profile, shelf life, and accessibility to expand personalized medicine to population scales.